Dietary Fiber-Microbiome Interactions: Elucidating Mechanisms to Suppress Multi-Drug Resistant Organisms in the Human Gut

Asymptomatic carriage of MDROs increases the risk of infection for the carrier and members of the community
to whom they may transmit the organism. Due to the increased incidence of community-acquired MDRO
infections, there is a pressing need to identify factors influencing MDRO colonization. While diet has been shown
to modulate the dynamics and metabolite profiles of human gut microbiota, we lack a detailed and quantitative
understanding of how specific dietary factors and human gut microbiome impact MDRO carriage. By integrating
a longitudinal human study coupled to a novel sequencing-based approach to elucidate dietary species,
advanced computational modeling, high-throughput construction of human gut communities and germ-free
mouse experiments, will revolutionize our understanding of the multi-scale fiber-dependent interaction networks
shaping MDRO (Clostridioides difficile, vancomycin-resistant Enterococci, third generation cephalosporin-
resistant Enterobacteriaceae, and carbapenem-resistant Enterobacterales) fitness and colonization of the
mammalian gut. In Aim 1, we will perform a prospective, longitudinal study of community-based participants to
elucidate the mappings between diet, human gut microbiome taxa, microbial pathways and MDRO carriage. We
will go beyond food intake self-reporting which is limited by systematic biases, to track human diet using a DNA
sequencing methodology referred to as FoodSeq. Leveraging the longitudinal data, dynamic computational
modeling will reveal microbe-microbe interaction networks across individuals. To identify the key dietary fibers
and human gut species shaping MDRO colonization, we will use a high-throughput and automated human gut
community culturing pipeline. The species identities as well as the specific combinations of these species will be
selected using a novel microbial genome-to-function deep machine learning model (data-driven Community
Genotype-Function or dCGF) that predicts MDRO abundance as a function of dietary fibers and the genetic
features of constituent community members. Using this expanded design-test-learn (E-DTL) approach, we will
identify combinations of species and dietary fibers that significantly influence MDROs fitness in human gut
communities. Analysis of the model using explainable artificial intelligence techniques will reveal genes/pathways
within constituent community members that impact MDRO fitness, providing mechanistic insights beyond the
taxonomic level. In Aim 3, we will use dCGF to design robust and maximally inhibitory or enhancing species-
fiber combinations for characterization in a murine C. difficile model. We will evaluate the ability of these designed
species-fiber combinations to decolonize C. difficile from the murine gut. Overall, this proposed research will
provide critical data and models across multiple scales to understand the interplay between diet, the gut
microbiome, and MDRO carriage. Our results will inform future interventions aimed at reducing MDRO carriage,
transmission, and infections in the community. Finally, this systems biology framework will be generalizable to
study other bacterial pathogens, environmental factors, and microbiome functions.

Public health relevance
Although diet is a major variable impacting the dynamics and functions of human gut microbiota, we lack a quantitative understanding of specific dietary fibers and human gut bacteria that combine to shape the carriage of multi-drug-resistant organisms. The proposed research integrates a longitudinal cohort study, advanced computational models, high-throughput human gut community culturing and germ-free mouse experiments to elucidate the multi-scale networks driving MDROs colonization and fitness. We hypothesize that specific dietary fibers and commensal human gut bacteria limit the ability of MDROs to colonize the human gut.